Alternative NF-kB activation in post-chemotherapy setting to elucidate novel mechanisms of ovarian cancer relapse

Project Summary
Ovarian cancer is the most lethal gynecological malignancy in the United States and although patients initially
respond to cytotoxic chemotherapy, most relapse with chemoresistant disease within 24 months. There are
several critical gaps in our knowledge of the mechanisms that support disease recurrence but research over the
last decade support the notion tumor-initiating cells (TICs), a subpopulation of drug resistant tumor cells, are
responsible for facilitating relapse and combination therapies targeting these elusive cells may lead to longer
remission or even cures. Although numerous genes and signaling pathways have been implicated in maintaining
TICs, there are several critical gaps in our understanding of the processes these cells use to survive cytotoxic
chemotherapy and successfully re-establish tumors. Our previous studies revealed an important role for
alternative NF-kB signaling in regulating stemness genes and supporting chemotherapy resistance. NF-kB is a
family of transcription factors that respond to signals in the TME to promote proliferation, chemoresistance, and
survival of cancer cells through activation of either RelA or RelB transcription factors. Clinical data from patients
undergoing neoadjuvant chemotherapy show that genes encoding alternative NF-kB family members are
significantly elevated in tumors resected following cytotoxic chemotherapy relative to pre-treatment levels.
Recent findings in our lab also implicate RelB in isolation and nutrient stress. These data lead us to our central
hypothesis that alternative NF-kB activation is critical for maintaining tumor-initiating cells that facilitate ovarian
cancer relapse. To investigate this hypothesis, the student will 1) Perform limiting dilution spheroid formation and
xenotransplantation studies using RelB or control knockout ovarian cancer cells and 2) investigate the
requirement for RelB signaling in metastasis ability in the presence and absence of chemotherapy. These
experiments will provide critical evidence not currently addressed in the parent grant or in prior published work
to distinguish the role of RelB in chemotherapy resistance versus tumor-initiating cell phenotypes. Given the
strong initial response to chemotherapy, it is of great interest to identify mechanisms that maintain TICs in ovarian
cancer. NF-kB regulates several gene programs that support stemness and survival pathways. Clarifying
whether this pathway imparts only chemotherapy resistance or whether it also supports long-term survival of
TICs and regeneration of heterogeneous tumors will improve our understanding of NF-kB in relapse and will
inform future therapeutic directions.

Public health relevance
Narrative Ovarian cancer is usually diagnosed at a late stage when survival is only about 10%, rendering this disease the deadliest gynecological malignancy. Disease recurrence is the major cause of mortality and despite a greater understanding of ovarian cancer biology there have been no significant improvements in mortality rates in the last five decades. Investigation of tumor cells that are resistant to chemotherapy and have the capacity to regenerate tumors is crucial for achieving cures for ovarian cancer patients.